PostureCheck: A vision-based compensatory-posture-detection tool to enhance performance of the BURT® upper-extremity stroke-therapy device

Summary / Abstract This Small Business Innovation Research (SBIR) Phase-I project proposes the development of an image- processing-based tool, named PostureCheck™, aimed at automatically detecting when patients perform undesirable compensatory movements during robot-assisted upper-limb rehabilitation exercises. The system will be based on a standard video camera (e.g., GoPro) that will be used to capture the movements of the subject. The automatic detection of undesirable compensatory movements is especially important when patients use a rehabilitation robotic system with minimum supervision, i.e. when a single therapist oversees the therapeutic sessions of multiple patients simultaneously. In this context, PostureCheck™ may be capable of tracking robot-assisted rehabilitation exercises and enable feedback modalities to discourage the performance of undesirable compensatory movements. Our long-term goal is to integrate PostureCheck™ with the Barrett Upper-extremity Robotic Trainer - BURT®, which we developed with special emphasis on stroke rehabilitation. The combination of PostureCheck™ with the BURT® device would be ideally suited for deployment in “Robotic Gyms”, where a single therapist oversees the therapeutic sessions of several patients simultaneously, thus allowing rehabilitation centers to offer high-dosage, high-intensity interventions despite the limited number of therapists currently available in the US. To demonstrate the feasibility of the proposed concept, we will develop PostureCheck™ to detect the most common compensatory movements automatically. To achieve this goal, we will rely on recently developed artificial intelligence (AI) methods referred to as Deep Learning. These methods have recently broken records in the human-posture analysis, joint-skeleton detection, and recognition of human activities using a single inexpensive camera. The proposed video-based PostureCheck™ tool will be the first system to exploit the capabilities of hybrid Deep Neural Networks, for real-time detection of compensatory movements during robot- assisted rehabilitation. The proposed SBIR Phase-I activities are organized in three aims. In Aim 1, feedback from rehabilitation experts at Spaulding Rehabilitation Hospital will be used to collect video data and to label compensatory movements observed during the performance of robot-assisted rehabilitation exercises by using the BURT® system. In Aim 2, Deep Learning techniques will be used to develop a robust detection of undesirable compensatory movements during the performance of robot-assisted rehabilitation exercises. Finally, in Aim 3, the algorithms developed in Aim 2 will be optimized. Specifically, we will test implementations that are suitable to generate real-time feedback. Computationally efficient implementations of the algorithms will enable - in future studies - the development of new modalities of control of the rehabilitation robot with the objective of discouraging undesirable compensatory movements.

Public health relevance
Project Narrative Each year, nearly 800,000 Americans suffer from a type of stroke that particularly weakens one side of the body. During upper-limb rehabilitation, appropriate feedback from a therapist to discourage stroke survivors from performing undesirable compensatory movements results in better motor recovery and - eventually - improved function. This proposal aims to develop a novel video-based tool, named PostureCheck™, to detect undesirable compensatory movements and enable automatic corrective feedback to the patient during robot- assisted upper-limb therapy.